Grandmother Caregiving, Family Dynamics, and Child Development in Rural Pakistan: a Mixed Methods Approach

PROJECT SUMMARY. Achieving optimal child socioemotional and cognitive development (SECD) is a global
public health priority. Poor development has been linked to low educational attainment, low wage earnings, and
poor adult health. Promoting optimal child SECD outcomes necessitates engaging key caregivers, but the
majority of psychosocial interventions to promote child SECD target mothers and fail to incorporate a family
systems approach. Across cultural contexts, grandmothers are often key advisors or decision-makers on
maternal and child health issues. Despite their influential roles, grandmothers are often omitted from
interventions and this exclusion can lead to diminished intervention impacts. Understanding how grandmothers’
roles evolve, impact child outcomes, and shape household practices in early life is essential to informing
interventions. Further, conflicts between mothers and grandmothers, two key caregivers in early life, may lead
to suboptimal caregiving practices and ultimately, poor child SECD. Research is limited on how the grandmother-
mother relationship quality affects household caregiving practices, especially in low-resource contexts.
The goal of this proposed predoctoral Diversity Supplement is to prepare the applicant for a successful
transition to a postdoctoral fellowship, and ultimately an independent investigator career, with a focus on
designing, implementing, and evaluating interventions to promote optimal child SECD. This will be accomplished
by individualized mentorship and didactic training to: 1) develop new skills in intervention development and
implementation science, 2) strengthen professional development skills, specifically in oral and written
communication, dissemination, and grant-writing, and 3) successfully apply and transition into a postdoctoral
fellowship. The outstanding mentorship team provides complementary and interdisciplinary expertise to support
and prepare the applicant for transition from predoctoral to postdoctoral training.
The goals of the proposed mixed methods dissertation research are to (1) estimate associations between
grandmother involvement across early life and child SECD at age 6, (2) examine associations between
grandmother-mother relationship quality and household investments to promote child development, (3a)
qualitatively explore grandmother and mother views on caregiving roles, family dynamics, and grandmother
inclusion in SECD-promoting interventions, and (3b) synthesize research findings and use implementation
science principles to provide new insights on grandmother inclusion in psychosocial, SECD-promoting
interventions. The Bachpan Cohort, a longitudinal birth cohort in rural Pakistan, serves as the parent study.
Separate in-depth interviews of grandmothers and mothers from the Bachpan Cohort will be conducted at child
age 7. This mixed methods project will generate new insights on grandmother caregiving, family dynamics, and
impacts on child SECD. The research findings will be used to highlight implementation gaps and opportunities
and identify implementation strategies for grandmother inclusion in existing interventions in Pakistan.

Public health relevance
PROJECT NARRATIVE: Achieving optimal child development requires engaging all key caregivers within a family; however, grandmothers are often excluded from maternal and child health and development interventions despite their influential roles as advisors, caregivers, and decision-makers, especially on maternal and child health issues. This predoctoral Diversity Supplement proposes mentored research and training to enhance existing research experience and gain new skills in intervention development, implementation science, and professional development. Findings from the proposed work will help inform the design, implementation, and evaluation of caregiving interventions across high and low-income contexts to promote optimal child development.